Blastema-independent Mechanism for Regeneration in Salamanders

PROJECT SUMMARY
While human and other mammals are limited in their abilities to regenerate, the salamanders, including
Ambystoma mexicanum (axolotl) are highly regenerative and have provided numerous insights into the
mechanisms of organ repair. Upon injury, axolotls generate “blastema” tissue at the wound site, which harbors
multipotent progenitors that engage in regenerative healing, contributing to multiple newly forming cell types.
The inability of mammals to form multipotent blastema cells is commonly thought to be the key barrier to true
regenerative wound healing. Axolotls can also regenerate skin, which normally consists of an epidermis, a two-
layer dermis as well as many secretory glands. Contrary to the prevailing notion that complete tissue
regeneration requires blastema, we now show that the axolotl skin regenerates without a blastema and that, in
fact, blastema formation represses glandular skin regeneration.
This application will focus on defining a novel cellular and signaling mechanism of blastema-independent
skin regeneration in salamanders. To achieve this goal, this project will leverage the analytical strengths of the
so-called Accessory Limb Model (ALM) – a highly tractable wound model system in axolotls that can be
experimentally directed to either: (i) rapidly regenerate gland-containing skin without a blastema, or (ii) form a
blastema when presented with a deviated nerve and display prominently delayed skin regeneration. Using a
combination of live axolotl imaging, lineage tracing, single-cell RNA-seq, functional protein delivery, and gene
perturbation assays in the ALM model, in our first aim we will establish if amphibian skin gland regeneration
critically depends on epidermal-dermal interactions and if these interactions are prevented in blastema-forming
wounds due to the immaturity of their fibroblasts. The second aim is to uncover new signaling and epigenetic
mechanisms of gland neogenesis in regenerating skin. In particular, we will establish the activating role of the
Bone Morphogenic Protein ligand BMP7 and the counterbalancing role of its antagonist GREMLIN and the
activating role of Class II histone deacetylase HDAC10 – top-listed differentially expressed genes in our RNA-
seq studies – on gland regeneration and skin fibroblast lineage maturation.
The study premise is strong, based on substantial preliminary data. The proposed studies are
significant because they will introduce amphibian skin as a novel model for studying mechanisms of skin
regeneration and will advance knowledge on skin cell types in amphibians. The proposed studies are innovative
because they will establish a novel paradigm of blastema-independent regeneration and will identify new skin
regeneration-inducing epigenetic and signaling factors. Ultimately, we want to be able to translate new
knowledge learned from this amphibian model system of blastema-independent skin regeneration to better
understand skin regeneration mechanisms in mammals, whose tissues typically heal without a blastema.

Public health relevance
PROJECT NARRATIVE Conventionally, the highly regenerative abilities of adult salamanders have been attributed to the “blastema” tissue that forms at the wound site and harbors many multipotent progenitors. Contrary to this prevailing dogma, we now show that skin in salamanders regenerates without a blastema. This application will explore a previously unknown mechanism by which dermal-epidermal interactions in blastema-less wounds drive regeneration of new skin, complete with many glands.